Training and Mentoring Core

2) Training and mentoring core (Aim #1 and 2) PUI Faculty Mentoring (Aim #1). Our goal in regard to our PUI colleagues is to provide them with the infrastructure and support to become successful biomedical researchers capable of developing a sustainable research and training program on their campus. To accomplish this goal, we will provide professional development and intensive mentoring. Each PUI faculty researcher is required to identify a mentor in his/her research area. The MS-INBRE administration will assist them in this process if necessary by matching them with a pool of potential mentors. Each mentor is subject to review and EAC approval as described in detail in the section